Encoding of probability distributions of 3D estimates in mind and brain

Project Summary
One of the most influential theories of biological vision considers visual perception as a process of Bayesian
inference. In order to make inferences about the external world a successful visual system must take into
account the uncertainty of neural computations. In the particular case of depth perception, the focus of this
project, Bayesian models postulate that uncertainty is explicitly represented as probability distributions defined
over possible 3D interpretations of a scene. Only this knowledge allows the integration of multiple sources of 3D
information to achieve Bayesian optimality. A large body of data compatible with this theory comes from studies
involving depth discrimination, where it is indeed found that variability in perceptual responses becomes smaller
as more depth cues are added to a stimulus. Here it is questioned whether this data is evidence that behavioral
variability stems from neural noise representing uncertainty of 3D estimates. Instead, an alternate theory is
proposed, which does not require this representation. Beyond being more parsimonious, this theory can also
predict the same findings that seem to confirm the Bayesian predictions.
This exploratory research proposal lays out two testable predictions of this new theory, termed Intrinsic
Constraint (IC), for which (1) the brain does not represent probability distributions over 3D properties and (2)
perceptual variability in depth discrimination tasks does not reflect uncertainty encoded in these probability
distributions. In contrast to the Bayesian account, the IC theory postulates that responses to different 3D stimuli
vary in magnitude instead of perceptual noise. In particular, stimuli that according to Bayesian models allegedly
have different reliabilities for the IC model elicit different perceptual gains. Combining cues increases the
perceptual gain and this factor, not higher precision, enhances performance in depth discriminations tasks. This
prediction gives the IC model the explanatory power necessary to support its viability as a theory of 3D
perception. Testing the validity of either theoretical account will be achieved through the synergetic collection of
behavioral and fMRI data. First, it will be determined whether the Just Noticeable Difference (JND) of a two-
interval depth discrimination task measures stimulus reliability or noise associated with memory retention.
According to this second interpretation, it is the perceptual gain that determines the changes in physical depth
required to overcome this task related noise, in agreement with the IC account. Second, an fMRI technique that
can estimate both the magnitude and noise of probability distributions encoded in neural population activity will
provide critical converging evidence of the existence (or absence) of neural encoding of 3D uncertainty. In
summary, this research project will bring together the two separate fields of research of visual perception and
visual short-term memory, with investigations leveraging behavioral and fMRI methods for addressing a
fundamental problem in vision science.

Public health relevance
Project Narrative Recent advances in medical technology are relying on 3D imaging for enhancing the capability of healthcare professionals to view anatomical information for critical diagnoses and to efficiently perform non-invasive procedures such as laparoscopic surgery. To best tailor them to human capabilities, the design of these vitally important instruments requires the fundamental understanding of how 3D information is processed by the visual system and, in particular, what are the sources of noise that affect 3D driven perceptual or motoric tasks. Aim of this proposal is to revolutionize the way we think about this process, through novel empirical investigations leveraging psychophysical and fMRI methods to test a new theory of 3D visual processing.